Targeting tumor microenvironment-mediated radiopharmaceutical therapy resistance in prostate cancer

PROJECT SUMMARY
Radiopharmaceutical therapy (RPT) is a clinically validated approach to deliver therapeutic radiation precisely
to tumor tissue. PSMA-targeting RPT (Pluvicto) is effective for the treatment of metastatic castration-resistant
prostate cancer. However, therapy resistance and relapse uniformly occur. Therefore, there is an urgent need
to define targetable mechanisms that limit durable RPT responses. In tumors, RPT induces DNA damage,
cancer cell death, and production of the immuno-regulatory small molecule cGAMP. cGAMP drives the
expression of type I interferon (IFN) that promotes anti-tumor adaptative immune responses and contributes to
reversing the immune suppression observed in the microenvironment of prostate cancer bone metastases.
Alternatively, cGAMP-mediated signaling is corrupted in a subset of prostate cancer tumors with high
expression of the ectonucleotidase ENPP1. ENPP1 degrades cGAMP to produce adenosine, which has potent
immuno-suppressive effects. The proposed research will test the hypothesis that in ENPP1-low tumors, PSMA-
RPT will trigger IFN production and anti-tumor immune responses. We further hypothesize that in ENPP1-high
tumors, PSMA-RPT will drive adenosine-mediated immunosuppressive effects that will be prevented by
pharmacological ENPP1 inhibition. Two UCLA investigators with complementary expertise in innate immune
signaling and RPT therapy will guide the proposed research. In Specific Aim 1, the role of ENPP1 in regulating
177Lu-PSMA-RPT-driven IFN signaling in pre-clinical models will be defined. Isogenic PSMA+ prostate cancer
cell lines will be engineered to model the heterogeneity of ENPP1 expression observed in human tumors. In
implantable tumor models, the effect of 177Lu-PSMA-RPT on tumor IFN signaling will be evaluated in the
context of high or low tumor ENPP1 expression. A luciferase-linked IFN response reporter and bio-
luminescence imaging will be applied to track IFN signaling in tumors. ENPP1 blockade using a small molecule
inhibitor will be tested to modulate 177Lu-PSMA-RPT -induced IFN signaling responses in tumors expressing
high levels of ENPP1. In Specific Aim 2, the efficacy of combination 177Lu-PSMA-RPT and ENPP1 inhibitor
treatment will be tested using 2 syngeneic prostate cancer models in immunocompetent mice. Tumor growth
will be monitored by µCT, and tolerability will be assessed by multi-parametric blood marker analysis. 177Lu-
PSMA-RPT and ENPP1 inhibitor-induced alterations in the tumor immune microenvironment will be evaluated
using flow cytometry and single-cell RNAseq analysis of tumor-infiltrating lymphocytes. The anti-tumor activity
of the 177Lu-PSMA-RPT and ENPP1 inhibitor combination therapy will be confirmed in mouse models of
prostate cancer bone metastasis. This research will apply genetic, pharmacological, and imaging approaches
to define new tumor microenvironment-driven RPT resistance mechanisms. If successful, these studies will
provide the rationale for new combination treatment strategies and patient stratification approaches to unleash
the potential immune-activating properties of RPT.

Public health relevance
PROJECT NARRATIVE FDA approval of radiopharmaceutical therapy (RPT) for the treatment of metastatic castration-resistant prostate cancer in 2022 represented a paradigm shift in the management of this incurable malignancy. However, resistance and relapse occur uniformly. This proposal outlines a new collaboration between two UCLA investigators with complementary expertise in immune signaling and RPT that aims to define immuno- metabolic RPT resistance mechanisms that can be targeted to enable long-lasting disease control.